CBPR: Extending the Use of Innovative Methodologies in the Behavioral & Social Sciences

Project Summary/Abstract
The need for the use of innovative methodologies in the behavioral and social sciences has been widely
noted. Innovative and community-engaged approaches to research and interventions are essential to address
social and physical environmental determinants of population health and more specifically racial and ethnic
inequities in health, which aligns with NIH's mission of uncovering new knowledge that will lead to better
health for all. There is a need to enhance capacity in innovative methods for researchers conducting
behavioral and social sciences research (BSSR) particularly in the context of community-engaged
approaches. One such approach, community-based participatory research (CBPR), is innovative in and of
itself for many researchers conducting BSSR, and there are also numerous specific innovations within the
context of a CBPR approach that are particularly relevant to the mission of NIH. These include the integrated
use of mixed methods (combining qualitative and quantitative data), innovative research designs that
complement randomized controlled designs, methods to advance dissemination and implementation science,
and methods for examining the combined influence of physical environmental and socioeconomic factors on
behavioral and health outcomes. Further, there are few opportunities for both early-career and established
researchers to engage in a co-learning process facilitated by experienced academic-community faculty teams.
Finally, there is a need to promote the diversity of the BSSR workforce, including increasing participation of
researchers from underrepresented racial, ethnic, and economically and educationally disadvantaged groups.
Thus, the overarching goal of the proposed research education program renewal, Community-Based
Participatory Research: Extending Capacity to Use Innovative Methodologies in the Behavioral and
Social Sciences (the Extend Program), is to enhance knowledge and skills in the use of innovative
methodologies in BSSR within the context of CBPR, in partnership with the communities involved, to
examine and address health inequities. The Extend Program will be carried out by the Detroit Community-Academic Urban Research Center (Detroit URC), a CBPR partnership established in 1995 which aims to
enhance capacity of community and academic entities to conduct and foster CBPR to promote health equity,
in conjunction with Community-Campus Partnerships for Health (CCPH), a national non-profit membership
organization that promotes health equity through community-academic partnerships. The program includes
three components: integrated educational activities for academic-community research teams involving an
intensive skill development short course and mentoring and career development activities; ongoing learning
and capacity-building using a train-the-trainers model and the continuation of a Community-Academic
Scholars Network; and widespread national dissemination activities.

Public health relevance
Project Narrative Community-Based Participatory Research: Extending Capacity to Use Innovative Methodologies in the Behavioral and Social Sciences (the Extend Program) is an innovative national training program for behavioral and social science researchers, in partnership with the communities involved, to advance scientific research skills in community-based participatory research with significant enrollment of participants from diverse racial, ethnic, and economically and educationally disadvantaged groups. The program is composed of three components: integrated educational activities for academic-community research teams involving an intensive skill development short course and mentoring and career development activities; ongoing learning and capacity-building through a train-the-trainers model and Community-Academic Scholars Network; and widespread national dissemination activities.